Impacts of Discriminatory Mortgage Lending Practices on Obesity

Project Abstract
Limited access to food and physical activity (PA) resources as well as poor social and economic neighborhood
conditions have been linked to low diet quality, physical inactivity, and elevated body mass index (BMI). Yet,
mixed findings may be due to gaps in understanding (1) the root causes of unequal allocation of such
neighborhood resources, and (2) the paths by which neighborhood conditions influence obesity. Root causes
such as housing policies have received little attention in obesity research and yet this may be critical to
addressing the epidemic. A key example is historical ‘redlining,’ where, between the 1930s and 1970s, areas
throughout the United States were designated as “high risk” based on the neighborhood’s racial composition.
Residents were systematically denied access to home purchasing. Poverty and segregation patterns in
redlined areas persisted; yet there is variation in the subsequent demographic shifts that have occurred.
Housing discrimination continues and may increase obesity disparities via heightened exposure to obesogenic
environments. We seek to address knowledge gaps by estimating longitudinal paths from historical and current
racially biased mortgage lending to BMI in a longitudinal cohort of Black and white adults. The project specific
aims are to: 1) Determine whether historically redlined neighborhoods have higher levels of obesogenic
neighborhood conditions and resident BMI through dietary behaviors and PA than non-redlined neighborhoods
(using baseline residential locations,1985–86); 2) Estimate longitudinal paths between changes in historically
redlined neighborhoods and BMI through changes in obesogenic neighborhood conditions, dietary behaviors,
and PA (using five timepoints of data, 1985–86, 1992–93, 2005–06, 2010–11, and 2015–16); and 3) Estimate
longitudinal paths between rates of current place- and race-based biased mortgage lending (data from 1990–
93, 2003–06, 2008–11, and 2013–2016) and changes in BMI, through changes in obesogenic neighborhood
conditions, dietary behaviors, PA, discrimination, and homeownership (data from 1985–86, 1992–93, 2005–06,
2010–11, and 2015–16). We achieve these objectives using the Coronary Artery Risk Development in Young
Adults Study (CARDIA) which is a longitudinal cohort with diet, PA, environmental, and sociodemographic data
collected for 5,115 white and black U.S. adults aged 18-30 years residing in four cities with redlining histories:
Birmingham, AL, Oakland, CA, Chicago, IL, and Minneapolis, MN. We will link historic redlining maps and two
indices of place- and race-based biased mortgage lending, using mortgage data, to CARDIA participants’
residential locations. We will estimate longitudinal paths from changes in residing in areas that were historically
redlined and areas with current biased mortgage lending to BMI changes through dynamic neighborhood
conditions, discrimination, homeownership, PA, and dietary behaviors. The results will deliver the needed
evidence to guide housing and neighborhood policy by understanding long-term effects of historical redlining
and current biased mortgage lending underlie neighborhood and obesity disparities.

Public health relevance
Project Narrative We seek to understand whether and how historical and current mortgage discrimination impacts obesity disparities through changes in neighborhood and resident behaviors. We propose to use a large longitudinal cohort of white and Black adults residing in four cities with mortgage discrimination histories to understand the paths by which mortgage discrimination may influence racial disparities in body mass index changes through dynamic neighborhood conditions, discrimination, homeownership, physical activity, and dietary behaviors. The results will deliver the needed evidence to guide housing and neighborhood policy by understanding whether and how long-term effects of historical mortgage discrimination and current biased mortgage lending underlie neighborhood and obesity disparities.